Identifying Hidden Relational Processes that Fragment Care for Older Adults with ADRD and Multimorbidity: A Social Network Analysis Approach

Abstract
Background: Care fragmentation is a major challenge for older adults living with Alzheimer's Disease and
Related Dementias (ADRD) and multimorbidity. Those in this population who are adversely affected by social
determinants of health (SDoH) are particularly vulnerable to the negative outcomes associated with care
fragmentation due to complex care needs, cognitive impairments, and social barriers. Care fragmentation is
associated with medical errors, poor patient experience, billions of dollars in wasteful healthcare spending, and
increased mortality. Although care coordination can mitigate care fragmentation and reduce social barriers
associated with disparities in health outcomes, it demands collective efforts and interdependent relationships
by clinicians across care teams and sites. Care coordination research has primarily focused on care tasks or
components and standardized tools. The complex, dynamic, and interdependent relationships among clinicians
through which care is delivered and coordinated have not been sufficiently evaluated.
Approach: Based on my previous work, I propose that this gap be addressed using social network analysis
(SNA) and electronic health record (EHR) data. Use of SNA and EHR data may better evaluate system- and
patient-level clinician networks across settings and over time (during K99) and explicate how clinician networks
relate to patients' social context and health outcomes (during R00) for older adults with ADRD and
multimorbidity. Specific Aim 1 will map the system-level clinician network for a cohort of over 90,000 older
adults with multimorbidity, including ADRD, using a combination of structured and unstructured EHR data.
Specific Aim 2 will detect and describe patient-level clinician networks for older adults with ADRD and identify
characteristics of weak networks that could be associated with fragmented care. Specific Aim 3 will identify
relational processes that are influenced by SDoH and contribute to disparities in health outcomes for older
adults with ADRD. I hypothesize that patients more adversely affected by individual- and community-level
SDoH are more likely to be cared for by clinicians in peripheral system positions, fragmented network
structures, or networks weakening over time, and that having peripheral, fragmented, or weakening clinician
networks will be associated with higher costs and risks for hospitalization and mortality.
Mentoring and Training Plan: I will work with a highly interdisciplinary mentorship team of experts in data
science, complex systems, health disparities, bioinformatics, health services and outcomes, computational
social science, stakeholder engagement, primary care, ADRD, and aging research. My mentorship team will
guide my training to gain competencies in longitudinal SNA and natural language processing during the K99.
This K99/R00 award is vital for continuing my progress in achieving my career goal of establishing an
independent, transdisciplinary research program to improve care coordination, thereby enhancing healthcare
quality and equity for older adults with multimorbidity, particularly those living with ADRD.

Public health relevance
Narrative Older adults with Alzheimer's Disease and Related Dementias along with other chronic conditions face substantial care coordination challenges due to their cognitive impairments and complex care needs, making them particularly vulnerable to the negative outcomes associated with care fragmentation. This proposal uses social network analysis and electronic health record data to uncover the interdependent network of relationships between clinicians involved in coordinating care across settings and over time, as well as the contribution of such clinician relationship networks to disparities in health outcomes for this population. Greater transparency in these networks has the potential to inform and empower patients, assist clinicians, and optimize health system operations to advance healthcare quality, efficiency, and equity for patients vulnerable to care fragmentation.